Implementation Strategies for a Pharmacist-Led Community-Based Care Transition Program for Rural Older Adults with Dementia and their Care Partners

PROJECT ABSTRACT
Older adults living with Alzheimer’s disease and related dementias (ADRD) experience remarkably complex
care transitions after hospitalization. Over half have medication problems (e.g., errors, discrepancies,
inappropriate use), increased care partner burden, health-related (e.g., behavioral symptoms), and social
needs after the care transition home. Our team has a sustained evidence-based care transition program for
rural older adults, the Region VII Area Agency on Aging Community Care Transition Initiative (CCTI), including
a community health worker (CHW) home visit and telehealth pharmacist medication review that addresses
medication discrepancies and optimization, social and health-related needs, provides referrals and follow-up.
Gaps in our knowledge of individual and organizational determinants to inform effective adaptations for rural
older adults with ADRD and their care partners and successful implementation interventions appropriate for
rural Area Agencies on Aging exist. The overall objective is to identify the key factors for adapting the CCTI for
rural older adults with ADRD and their care partners (i.e., CCTI-ADRD) and to test the feasibility and
acceptability of implementing the adapted CCTI-ADRD. The Tailored Implementation in Chronic Disease
(TICD) framework informs our aims. AIM 1: Determine factors for adapting and implementing the Community
Care Transition Initiative-ADRD to address medication problems, care partner burden, and health and social
needs of rural older adults with ADRD and their care partners. We will conduct semi-structured interviews and
direct observations with key informants (those with ADRD and their care partners, CHWs, Area Agency on
Aging staff, and healthcare providers) and use rapid qualitative analysis and the TICD framework to prioritize
factors, critical adaptations, and implementation barriers and facilitators. With our community advisory board,
comprised of older adults with ADRD and their care partners, pharmacists, CHWs, and Area Agency on Aging
members, we will reach a consensus on our implementation toolkit and pilot study protocol. AIM 2: Test the
feasibility and acceptability of implementing the Community Care Transition Initiative-ADRD in three rural Area
Agencies on Aging. Using a mixed-methods implementation pilot study, we will assess our primary outcomes
of feasibility and acceptability of the implementation strategies. Secondary outcomes are implementation
fidelity, medication problems addressed, care partner burden, ADRD behavioral symptoms, and community-
based services provided. Direct observations, surveys, chart reviews, and semi-structured interviews with key
informants will be used. We will integrate our data, create a causal pathway diagram to examine why our
implementation strategies worked, and refine our toolkit. The expected outcome is our tailored implementation
toolkit to be tested further in a randomized hybrid effectiveness-implementation clinical trial. We will positively
impact rural older adults with ADRD and their care partners by reducing medication problems and unmet social
and health needs after the care transition home.

Public health relevance
PROJECT NARRATIVE The transition home after hospitalization for rural older adults with dementia and their care partners is an incredibly challenging time with increased risk of medication-related harm, health-related symptoms such as agitation and reduced function, care partner burden, and unmet health and social needs. This project will adapt an evidence-based, community care transition initiative for older adults with dementia and their care partners, design implementation strategies, and test its feasibility and acceptability in rural Area Agencies on Aging. The initiative includes community health worker home visits and telehealth pharmacist visits and is designed to address inappropriate medication use, manage difficult symptoms, provide care partner education and support, and connect individuals to social and health resources in their communities.